Regulation of B cells in the CNS

Project Summary
Central nervous system (CNS) inflammation as a result of viral infection, tissue injury, or autoimmunity is
associated with recruitment of various B cell subsets ranging from naïve, isotype class unswitched, isotype
switched memory B cells (Bmem) and antibody secreting cells (ASC). ASC have been a major focus of research
due to their reactivity to autoantigens in multiple sclerosis (MS), neuromyelitis optica and Ab encephalitic
diseases. However, beyond Ab secretion B cells are important modulators of immune responses by serving as
antigen presenting cells, producing pro- and anti-inflammatory cytokines, and participating in formation of tertiary
lymphoid structures (TLS) in non-lymphoid organs. TLS exacerbate local immune responses during chronic
inflammation. Their presence in the meninges correlates with subpial cortical demyelination and disability
progression in MS. An underlying feature of TLS is the activation of meningeal stromal cells, including follicular
reticular cells (FRC) which provide a structural network guiding leukocyte accumulation and orchestrating CNS
immune responses. Activated FRC are marked by upregulation of the mucin-type transmembrane protein PDPN,
lymphoid chemokines CXCL13, CCL19 and CCL21, extracellular matrix (ECM) and integrins, such ICAM-1,
which together support immune cell interactions in stromal niches. While some chronic inflammatory diseases
including MS are associated with sustained activated FRC dependent TLS formation, CNS viral infection elicits
transient FRC activation with no evidence for TLS despite ongoing inflammation during viral RNA persistence.
Context dependent plasticity and/or heterogeneity of FRC is supported by tissue and insult specific mediators of
stromal network activation and stabilization to form chronic TLS in distinct models. The mechanisms underlying
transient versus chronic meningeal FRC network activation and TLS during CNS infections remain
unexplored. The goal of this proposal is to define how B cell/stromal cell interactions shape adaptive antiviral
immune responses during acute and persistent infection established by neurotropic coronavirus. The Specific
Aims are to determine 1) the role of early CNS accumulating B cells in promoting meningeal stromal cell
activation and 2) signals sustaining CNS stromal cell activation and effects on local B cell differentiation and
diversity as well as control of viral persistence. We will test the hypothesis that IgD+ B cells participate in LTβR
dependent FRC activation by using select blocking approaches to define mediators activating stromal cells (anti-
PDPN and -CD20 treatment, LTβR blockade and cell type specific LTβ ablation) during acute infection. Aim 2
tests the hypothesis that sustaining FRC activation with distinct immune modulators during viral control retains
recruited B cells in stromal niches, thereby promoting local B cell maturation. A better understanding of reciprocal
FRC/B cell interactions within defined microenvironments will impact strategies to remodel FRC networks to
improve antimicrobial function, while minimizing pathological consequences.

Public health relevance
Project Narrative B cell populations infiltrating the central nervous system (CNS) are common hallmarks of neurotropic infections, the demyelinating disease multiple sclerosis (MS), as well as autoimmune encephalitis. However, their antibody-independent regulatory functions and crosstalk with resident meningeal stromal cells, which provide the platform for chronic B-cell aggregates associated with immune pathology in MS, require more extensive investigation. Using a viral CNS infection model to characterize cues associated with acute, resolving, and chronic activation of meningeal stromal cells and their effects on B-cell retention and function, results will unveil how meningeal immune responses can be manipulated to optimize parenchymal protective immunity and/or minimize pathology.